Naturalistic Social Communication in Autistic Females: Identification of Speech Prosody Markers

PROJECT SUMMARY
Autistic females are diagnosed at a significantly lower rate and at later ages than males. As a result, much less
is known about the female autism phenotype. Studies have indicated that diagnostic tools may be biased towards
males and that findings characterizing the autism phenotype may fail to capture females due to little or no female
representation in their sample. Emerging research has identified unique sex differences in the autistic population
across several modalities, including language. The handful of studies that have characterized language use in
autistic females have done so through examining word use, identifying nuanced ways that autistic females use
discourse markers, pronouns, and emotional words. These differences may contribute to autistic females’
heightened social motivation, using language to compensate for social difficulties, although no study has directly
explored this possibility. We propose to bridge this gap through a focus on speech prosody, an understudied
area of pragmatic language that allows individuals to convey meaning and emotion through speech. Prosody
plays an important role in social-communication and in the early detection of autism, yet few studies have
included females in their sample and no study has closely examined potential sex differences. In Aim 1, we will
characterize differences in key prosodic markers of pitch and tempo in young children (4-8 years) by sex,
diagnosis, and conversational content using a novel adaptation of natural language sampling methodology. In
Aim 2, we will use multi-modal data collected through an ongoing study (R01-HD103895-01A1) to explore the
relationship between speech prosody, social traits, and formal language. We hypothesize that the autistic (ASD)
group will significantly differ from the non-autistic (NA) group in multiple measures of pitch and tempo, and that
these differences will be exacerbated during conversation around a “special interest” topic. We predict that while
ASD females will display more “typical” prosody in common prosodic measurements of pitch, they will be
differentiated from ASD males and NA females in more socially complex measurements of intonation, speech
rate, and pause. We predict overall negative relationships between social measurements and speech prosody
markers associated with ASD: These relationships will be stronger for ASD females than males, while
relationships between speech prosody and language scores will be stronger for ASD males. Training aims
include advancing Ms. Putnam’s skills in multi-modal methodologies, eye tracking, language processing, and
statistical analyses. This project will enhance current understanding of speech prosody and how it relates to
other important aspects of the autism phenotype. By further characterizing the female autism phenotype, this
work will contribute to more timely diagnoses and comprehensive care of this understudied population.

Public health relevance
PROJECT NARRATIVE This proposed study will examine speech prosody in autistic females, a highly underrepresented population in research whose prosodic characteristics are largely unknown. Given that prosody is an early marker of autism, characterizing speech prosody in autistic females has the potential to improve their rate of timely diagnosis. Irrespective of sex, this study will be the first to take a comprehensive look at speech prosody using a battery of multi-modal assessments, which will enhance our knowledge of the associations between developmentally critical areas such as structured language, social skills, and adaptability around restricted and repetitive behaviors.